EPINEPHRINE EFFECTS ON MUSCLE GLYCOGENOLYSIS AND GLYCOGEN METABOLISM

This study is designed to elucidate the role of epinephrine on the regulation of muscle glycogen degradation, turnover and cycling by using 31p and 13c-nuclear magnetic resonance spectroscopy in vivo in healthy normal and type I diabetic subjects.